Elucidating Structural and Functional Alterations of CNS Pericytes on Chronic Brain Implants

PROJECT SUMMARY
Penetrating microelectrodes significantly advance our understanding of brain function and enable us to
restore motor and sensory control lost from neurological disorders. However, the efficacy of intracortical
microelectrodes for clinical therapy is limited by an inability to detect or modulate neurons over time and is
presumed to be due to severe bodily reactions to a foreign body. While the biological mechanisms regulating
device failure are poorly understood, emerging hypotheses suggests that neurovascular dysfunction plays a
significant role in enabling progressive neuron loss and tissue failure after device implantation. Neurovascular
health and function are governed in part by perivascular pericytes, specialized mural cells in direct apposition
with cerebral blood vessels. Pericytes demonstrate important roles regulating vascular tone, blood-brain barrier
integrity, and neuroimmune functions and have become increasingly recognized as prominent figures in the
pathogenesis of brain inflammation and disease. How device implantation disrupts the structure and function of
pericytes and the subsequent ramifications on neural health, glial activity, and vascular integrity are currently
unknown. Preliminary data suggests that device insertion alters the distribution and morphology of pericytes,
which occurs in tandem with neuronal calcium dysfunction, glial activation, and vascular deterioration.
For the F99 phase, I will determine how electrode implantation affects functional pericyte activity in vivo
using a genetically encoded calcium indicator GCaMP6s to characterize calcium signaling dynamics
exclusively within PDGFRβ+ pericyte cells. Additionally, I will train in the use of optogenetics to target and
modulate pericyte-specific responses during insertion and throughout implantation with the expected outcome
of promoting pericyte health, neuroprotection, and vascular function after brain injury. Adeno-associated viral
(AAV) transduction will be performed to visualize neuronal calcium dynamics following pericyte stimulation.
Finally, substantial fellowship efforts will focus on activities in professional career development in anticipation
of securing postdoctoral training during the K00 phase.
For the K00 phase, I will leverage my expertise of neural interface technology and neuroimmune
responses to continue identifying and characterizing mechanisms of neurodegeneration during brain injury and
use advanced neuromodulating techniques to treat or reverse pathology in brain diseases such as Alzheimer’s
disease and related dementia (ADRD). Activities during this phase will involve more directed career
development training that is tailored toward becoming a fully realized, independent ADRD investigator. In
summary, completion of the above-mentioned research aims and professional training backed by the generous
support of an NIH D-SPAN award will enable me to carve out a novel and innovative area of research at the
intersect of neural interface biology, neuromodulation, and neurodegenerative disease.

Public health relevance
PROJECT NARRATIVE Intracortical microelectrodes possess enormous therapeutic potential restoring motor and sensory function to neuro-disabled patients, yet unresolvable depreciations in device performance stemming from overwhelming foreign body responses hinder their clinical applications. How the structure and function of brain pericytes, principal components of the neurovascular unit and key mediators of neuroinflammation, are altered during microelectrode implantation and affect neuronal health and neurovascular function are currently unknown. Understanding the way in which intracortical microelectrodes alter the distribution, morphology, and function of pericytes and how pericyte function can be modulated to promote neuroprotection and cerebrovascular health after implantation will have profound implications on future therapies aimed at improving electrode-tissue integration, device performance and fidelity, and neurodegenerative brain injury and disease.